DIABETES PREVENTION TRIAL FOR TYPE II DIABETES (DDT 2)

Individuals with high risk for NIDDM, Alteration of life style such dietary modification, and physical exercise will ameliorate or delay development of NIDDM.